Women's Reproductive Health Research

ABSTRACT
The core academic mission of the Department of Obstetrics, Gynecology, & Reproductive Sciences at the
University of California, San Francisco is to promote health and prevent disease in women by developing a welltrained, productive cohort of clinician investigators who will conduct high impact basic science and clinical
research, discover practice-changing innovations, and ultimately become leaders in the field who continue to
train the next generations. The UCSF WRHR program has been funded since 1998 and has recruited exceptional
trainees and provided them with the critical skills and training to succeed as independent investigators. Sixteen
superb WRHR trainees have been recruited to the program; 14 have completed training and 2 are current
trainees. Our WRHR alumni have made major contributions to science including basic and translational
discoveries in reproductive health and breakthroughs in clinical research across the broad range of disciplines
within Obstetrics and Gynecology. Over the next 5 years, we propose to continue supporting our existing 2
trainees who have made excellent progress and show enormous potential, and then recruit 2 new outstanding
trainees to the program. To this end, trainees with particular research areas of focus and clinical specialties will
be recruited to pursue biomedical (laboratory-based), translational, and/or clinical research in reproductive
sciences. We will focus on opportunities for trainees to learn about core research methods as well as emerging,
cutting-edge scientific fields. Two research development pathways (RDPs) have been established to guide
trainees in need of additional formal research education (RDP I) and trainees who are more experienced at entry
into the program (RDP II). The Program Aims of the UCSF WRHR are: 1) To recruit and retain a cohort of
outstanding, well-trained reproductive and women’s health researchers who will advance scientific discoveries
in basic, clinical, and translational sciences; 2) To provide trainees with an individualized plan that provides the
necessary didactic training, guided research and career mentorship, and resources and environment required to
successfully transition to an independent researcher; 3) To support trainees by creating and sustaining strong
collaborations and programmatic links with institutional partners focused on training and mentoring junior
research faculty. Our extensive resources, dedicated mentors, supportive environment, and >25 years of
experience enable our WRHR program to thrive and continue to succeed in developing the next
generation of independent investigators that advance reproductive and women’s health and wellness.

Public health relevance
PROJECT NARRATIVE The overarching goal of our WRHR program is to provide a pathway to develop independent, well trained, and diverse women’s health researchers who will conduct high impact science, become leaders in the field, and train further generations of researchers. We propose a 5-year, intensive and individualized mentored WRHR training program at UCSF to develop independent research careers for Obstetrician/Gynecologists in clinical, translational, and basic science research in reproductive and women’s health. Such training, embedded in a well- established environment of collaboration and interaction among mentors and trainees, is a powerful approach to creating the next generation of researchers who will translate the findings from the laboratory and clinic for the betterment of women’s health.